Admin Supplement: Integrating pain-CBT into an mHealth analgesic support intervention for patients with chronic pain from advanced cancers

PROJECT SUMMARY/ABSTRACT
Pain affects approximately two thirds of patients with advanced incurable cancers. Cognitive Behavioral
Therapy for pain (pain-CBT) is an effective treatment for chronic pain from cancer. Unfortunately, pain-CBT in
its traditional format (60-minute, in-person sessions) is often unrealistic for patients with advanced cancer.
Behavioral treatments require substantial adaptation to meet advanced cancer patients' real-life needs, and
should ideally integrate with their pharmacotherapy (e.g. opioid) plans. Mobile health (mHealth) technology is a
promising strategy to deliver and ultimately disseminate brief pain-CBT interventions to cancer patients.
The goal of Dr. Azizoddin's K08 proposal is to develop a novel mHealth application that integrates brief pain-
CBT into an existing mHealth application designed to optimize opioid management for patients with chronic
pain from advanced incurable cancers. Leveraging co-mentor's app (R21-funded), Smartphone Technology to
Alleviate Malignant Pain (STAMP) is a patient-facing smartphone app that facilitates daily symptom and opioid
monitoring and delivers tailored pain education and advice. Following the NIH Stage Model for Behavioral
Intervention Development (Stage:1A&1B), Dr. Azizoddin will create STAMP+CBT, a novel intervention that
harmonizes psychological and medical support for advanced cancer pain. In AIM 1: the PI will develop and
refine STAMP+CBT by adapting pain-CBT for brief mHealth delivery through a series of iterative qualitative
interviews, and wireframe and user acceptability testing (AIM 1A). STAMP+CBT will be programmed and
tested in a small pre-pilot with the target population to inform app refinements (AIM 1B). In AIM 2: 60 patients
with chronic pain related to advanced cancer will be randomized to the app or usual care + digital cancer pain
education for 6 weeks. Feasibility of the study will be determined by examining recruitment/retention rates and
completion rates of app-delivered pain-CBT content. A subset of patients will complete qualitative debriefing
interviews to inform final app refinements. Measures will explore anticipated primary (pain interference) and
secondary pain outcomes to inform the design of a future (R01) efficacy trial of STAMP+CBT. Dr. Azizoddin's
research activities will be mentored by an interdisciplinary team of expert investigators in pain psychology
(Robert Edwards, PhD), palliative care clinical trials (Andrea Enzinger, MD & James Tulsky, MD), cancer pain
(Christine Miaskowski, PhD), and mobile health (Michael Businelle, PhD & Daniel Gundersen, PhD). This K08
proposal will allow Dr. Azizoddin to acquire training in: 1) adapting psychological pain interventions for cancer
populations, 2) learning rigorous methods to develop/refine behavioral mHealth interventions, 3) conducting
randomized clinical trials of behavioral interventions, and 4) conducting longitudinal analysis of momentary
pain/psychological mHealth data. This training program and structured mentorship under the guidance of
esteemed research faculty will provide Dr. Azizoddin with the support necessary to become a successful,
independent investigator, specializing in effective and scalable behavioral treatments to improve cancer pain.

Public health relevance
PROJECT NARRATIVE Chronic pain, a common and distressing complication of advanced cancer, is commonly treated with analgesics with minimal access to comprehensive biopsychosocial pain management approaches. Aligning with NCI's mission to advance scientific knowledge to help patients live longer, healthier lives, this K08 proposal seeks to improve cancer patients' pain self-management by adapting and integrating cognitive behavioral therapy for pain into an existing mHealth intervention designed to optimize pharmacologic management (e.g. daily pain/opioid monitoring and tailored advice) for patients with advanced cancer. This integrated psychological and pharmacologic mHealth intervention has strong potential to improve cancer pain outcomes and to readily disseminate pain management support and alleviate pain for a wide range of patients with advanced cancer.